Planning and Priority Setting Phase

Administrative CORE- Project Summary The Administrative Core is dedicated to strategizing the planning and implementation of our proposed partnership. Dr. T.-C. Wu of Johns Hopkins and Dr. Xiaowu Pang of Howard University will lead the development of the program and its pilot projects as Co-Principle Investigators. Leadership retreats will be established wherein expert advisors from our Internal Advisory Committee and Scientific Review Committee as well as ad-hoc consultants will steer the direction of the projects and overall partnership. The partnership will help to address barriers and disparities in cancer health, health education, and health-related professions. Transfer of cancer research knowledge and skills from the extensive established activities at Johns Hopkins to the minority-serving institution will greatly improve Howard University's research capacities. Extensive planning and administrative activates including emails, in-person meetings, teleconferences, seminars, and workshops will aid in the planning process. The proposed partnership has the strong support of leaders from both universities.

Public health relevance
N/A